Predictors of Post-COVID Clinical and Cognitive Consequences

Patients recovering from acute COVID-19 infection often suffer from a multitude of debilitating chronic physical
symptoms that can last up to 6 months or more. The incidence of fatigue, cognitive impairment and respiratory
symptoms are reported to be very high in the post-COVID period. The underlying pathophysiology of cognitive
impairment is unclear in these patients. Notably, sleep disturbances are common during this post-COVID
period, and sleep apnea has been associated with an increased risk for severe COVID infection. Thus, it is
conceivable that sleep fragmentation, per se, may confer an increased risk for chronic cognitive deficits in
Veterans post-COVID. Our proposed pilot project will determine if there is a link between post-COVID sleep
disturbances, sleep apnea and cognitive function. Knowledge gained from our examinations may guide
development of novel management pathways, i.e., mitigation of sleep disturbances may present a therapeutic
strategy for alleviating chronic post-COVID cognitive impairment.
Aim1 will investigate the effect of sleep duration and sleep quality on neurocognitive function in post-COVID
Veterans. Aim 2 will study whether the severity of OSA determines neurocognitive function Veterans who are
post-COVID. This is an observational study where we will gather retrospective as well as prospective data on
the long-term effects of COVID on neurocognitive function and sleep. Our long-term goal is to enhance
rehabilitation and recovery of function of Veterans suffering from post-COVID consequences that may arise
due to sleep disturbances, with the ultimate objective of improving the overall health and quality of life of
Veterans recovering from COVID-19 infection.

Public health relevance
There is a high incidence of neurological, respiratory, sleep disturbances and other negative sequelae that persist for many weeks after recovery from an acute COVID-19 infection. These may occur even after a mild infection and can be debilitating for the Veteran who may not be able to return to full function after the infection. One such adverse effect is cognitive dysfunction which is a common component of the post-COVID symptom complex. Our goal is to understand whether sleep disturbances or untreated sleep apnea contribute to the cognitive deficits after COVID-19 infection. Our long-term goal is to advance the rehabilitative health care of Veterans suffering from cognitive impairment by studying the delayed effects and impairments related to COVID infection and develop treatment pathways that will improve the overall health and quality of life of Veterans suffering from these delayed complications.